Therapeutic Targeting of WDR5 in the Glioblastoma Perivascular Niche

PROJECT SUMMARY / ABSTRACT: Glioblastoma (GBM) is a uniformly fatal brain cancer driven by a small
population of self-renewing, highly tumorigenic cells termed GBM stem cells (GSCs). Our long-term goal is to
find improved therapeutics for GBM by better understanding the biology that drives this disease. GBM tumors
have a complex microenvironment including a relatively proliferative perivascular niche containing GSCs
enriched for the stem cell marker SOX2+, and a distinct hypoxic niche that regulates resident GSCs through
hypoxic signaling factors. Because the cells within distinct GBM tumor regions are remarkably different from
each other, we believe that individual tumor microenvironments must be targeted with unique niche-specific
therapies. However, current culture models fail to replicate the complex microenvironments of GSCs, limiting our
ability to study and therapeutically target GBM. We therefore developed patient-derived GBM organoids, a
controlled ex-vivo system that contains both proliferative and hypoxic niches, as well as gradients of stem and
non-stem cells similar to those observed in patient tumors. We developed methods to 3-dimensionally label the
separate niches of organoid cultures and used these techniques to perform the first spatially-resolved functional
screen in any solid tumor. Our results pinpointed the epigenetic effector protein WDR5 as being uniquely
essential to GSCs growing in the proliferative niche of GBM organoids. The objective of this application is to
illuminate the roles of WDR5 in glioblastoma and determine whether disruption of WDR5 activity may have
therapeutic efficacy. To achieve this, we will test the central hypothesis that GSCs require WDR5 to maintain
bivalent gene expression within proliferative tumor niches, and that WDR5 can be targeted to
compromise GBM growth in vivo. We will test this through execution of the following specific Aims: 1)
determine if WDR5 activity is required for niche-specific GSC growth in vivo, 2) determine if WDR5 creates
embryonic stem-cell-like bivalent gene regulation in GBM, and 3) determine if targeting of WDR5 function yields
a therapeutic benefit in GBM preclinical models. The proposed research is an innovative first-of-its-kind study
that will verify the feasibility and efficacy of niche-specific targeted screening and drug identification. This
represents a significant advancement by using novel methodology and feasible new approaches to overcome
an experimental barrier across many cancer types. This conceptual and experimental framework can be applied
to a wide range of cancers, can unmask unique microenvironmental biology, and can allow rationally designed
combination therapies against niche-specific targets. The expected outcome of this work is an understanding of
the roles of WDR5 in GBM niche biology and evaluation of a novel blood-brain-barrier penetrant WDR5 inhibitor
in orthotopic brain tumors. There is an urgent need to develop novel therapeutic strategies that significantly
improve the survival of GBM patients. This proposal will investigate the mechanistic role of WDR5 in GBM
biology, while simultaneously testing a promising potential therapeutic in highly accurate preclinical models.

Public health relevance
PROJECT NARRATIVE: Glioblastoma (GBM) is the most common malignant primary brain tumor and among the most lethal due to their recurrence and therapeutic resistance. These properties are associated with a GBM stem cell (GSC) fraction present within distinct microenvironmental niches of the tumor and we have identified the protein WDR5 as specifically essential for GSCs to grow and maintain stem-cell-like biology in GSC-rich niches of GBM tumors. The successful completion of this proposal will yield an understanding of the roles of WDR5 in GBM niche biology and an appraisal of the therapeutic efficacy of inhibiting WDR5 in GBM.